Ultra-High Field NMR Magnets with Multifilament High Temperature Superconductors

PROJECT SUMMARY
We propose to develop a new technology pathway towards 1.5 GHz 1H NMR, by building a 28.2 T (1.2 GHz
1H)/1ppm, all-superconducting NMR demonstrator magnet using coils of the High-Temperature Superconductors
(HTS) Bi-2212 (Bi2Sr2CaCu2Ox) and Bi-2223 ((Bi,Pb)2Sr2Ca2Cu3Ox) nested inside an existing wide-bore, 12 T
Low-Temperature Superconductor (LTS) magnet. The novelty of our proposal is that the primary HTS conductor
technology will be Bi-2212, made using a process we have developed with DOE High Energy Physics support.
In contrast to existing commercial HTS NMR magnet technology that is reliant on REBCO (REBa2Cu3O7-δ) tape
conductor, Bi-2212 is a round, genuinely multifilament and isotropic conductor that does not suffer from the very
large screening current induced stresses and error fields of the large width, single filament REBCO coated tape
conductors. It is also presently made in 3-4 times longer lengths than REBCO, making it more appropriate for
our long-term goal of creating magnets for 1.5 GHz 1H/ 35.3 T NMR spectroscopy, where 40-60% of the field
must be provided by the HTS insert magnets. To make our proposal compatible with R01 funding possibilities,
we pair two inner Bi-2212 coils with a larger diameter Bi-2223 coil as the HTS insert magnet. This strategy has
two advantages: (i) we have more than 2 km of Bi-2223 and more than 3 km of Bi-2212 conductor available
at no added cost to this project; and (ii) we can use the two HTS conductors to generate almost 60% of the
total field as would be needed for going to 1.5 GHz magnets. The following capabilities available at the National
High Magnetic Field Laboratory (NHMFL) enable the proposal: (a) A 212 mm bore, high-homogeneity LTS
magnet supported by the Oxford Instruments (OI) team that built it; (b) a unique over-pressure heat treatment
furnace (OPHT) facility for reaction of the Bi-2212 coils at the scale needed for NMR magnets; and (c) the
essential expertise of NHMFL scientists and engineers with experience building high field magnets and magnetic
resonance equipment for biological and biomedical applications. Successful demonstration of ultra-high-field
NMR technology will meet the aggressive challenge of 1.3-1.5 GHz NMR articulated by the 2013 National
Academy Panel assessing U.S. high magnetic field needs.

Public health relevance
PROJECT NARRATIVE Nuclear magnetic resonance (NMR) spectroscopy is a powerful technique used to non-invasively identify metabolites and to examine the three-dimensional structure, dynamics, and interactions of proteins. We seek to develop superconducting magnet technology for next-generation NMR systems with 1.3-1.5 GHz 1H capability by a technology demonstration of novel Bi2Sr2CaCu2Ox HTS conductor and coil technologies pioneered at the National High Magnetic Field Laboratory.